SHOW-Forward: A pathway for enhancing participant diversity, enriching data, and improving access to a unique environmental epidemiology cohort

PROJECT SUMMARY
Well-characterized longitudinal epidemiological cohorts are crucial resources for identifying novel risk factors,
examining exposure-outcome associations, and determining the role of biomarkers in disease development and
progression. The Survey of the Health of Wisconsin (SHOW) is a unique environmental epidemiological cohort
where rigorous survey methodology was used to ensure state-wide participation from Wisconsin, resulting in a
representative sample. Based on our successful experience in participant recruitment, we propose to initiate
SHOW-Forward to further enhance diversity of the cohort, enrich already collected data and expand its access
to the research community to facilitate novel environmental epidemiology and translational research aligned with
the NIEHS mission. To accomplish these goals, we propose three specific aims. First, we will expand the SHOW
cohort through continued and enhanced outreach and engagement of underserved and underrepresented
populations in Wisconsin. Novel approaches for participant-centric biospecimen collection will be implemented
to reduce the burden for participants from rural areas with limited access to health care resources. Second, we
will develop the SHOW Real World Data Collaborative infrastructure as a foundation for secure integrative
environmental health research. Third, we will establish the administrative infrastructure to develop, refine, and
conduct participant recruitment, ethical and compliant acquisition, linkage, usage, analysis and sharing of PHI-
containing multi-dimensional data and annotated biospecimens. Ultimately, this collaborative infrastructure will
facilitate broad access to SHOW data and biospecimens, enable early detection and treatment of emerging
health issues, improve understanding of the role of environmental and lifestyle factors, harmful chemical
exposures, and genetics on human health, and unlock new pathways for evidence-based prevention of
environmentally caused diseases.

Public health relevance
PROJECT NARRATIVE Well-characterized longitudinal epidemiological cohorts are crucial resources for identifying novel risk factors, examining exposure-outcome associations, and determining the role of biomarkers in disease development and progression. The Survey of the Health of Wisconsin (SHOW) – a cohort representative of the state of Wisconsin has baseline and longitudinal follow-up data and environmentally annotated biological specimens on participants who consented for use of their data and specimens in future unspecified research, which makes SHOW an invaluable resource for environmental epidemiology research. We propose SHOW-Forward to further expand and diversify the SHOW cohort and establish the SHOW Real World Data Collaborative infrastructure to ensure enduring access for the scientific community to well-characterized and rich cohort data, including social determinants of health, multiple exposures, health outcomes, and biological specimens.